Development of a chemogenetically controlled RNA aggregation system and its application in elucidating the role of RNA foci in repeat expansion disease

ABSTRACT
Repeat expansion diseases are a group of over 40 severe neurological disorders that are caused by an
abnormal expansion of trinucleotide or hexanucleotide repeat sequences. While there are several proposed
mechanisms of repeat expansion disease pathogenesis, it is widely accepted that RNA-gain-of-function toxicity
is the major contributor to pathogenesis in several repeat expansion diseases. RNA-gain-of-function toxicity is
characterized by repeat expansion RNA sequestering of RNA-binding proteins (RBPs) and causing global
dysregulation in splicing events and cellular toxicity. Repeat expansion RNA is also known to form nuclear,
phase-separated aggregates of expansion RNA and RBPs, also known as RNA foci. However, the role of RNA
foci in RNA-gain-of-function toxicity is poorly understood. This is due to the fact that the only existing tools for
studying RNA-gain-of-function toxicity rely on expression of expansion repeats and correlation of RNA foci
formation with RBP sequestration and cellular toxicity. Several studies using the aforementioned methods have
shown that expression of long, foci-forming repeats elicits higher cellular toxicity compared to expression of
short, non-foci forming, repeats. However, it is unclear whether cellular toxicity is dependent on the formation
of RNA foci to reach toxic levels of RBP sequestration, or whether the increase RBP binding sites of longer
repeats is sufficient to reach toxic levels of RBP sequestration and the formation of RNA foci is merely a
byproduct. By comparing cellular toxicity and levels of protein sequestration in cells that form foci, to cells that
do not form foci but harbor the same length repeat RNA, we can directly assess whether RNA foci formation is
required for cellular toxicity in repeat expansion diseases. To do this, inducible RNA foci formation is required.
Recently, I have developed an approach that allows, for the first time, for chemogenetic controlled RNA
aggregation. This technology presents the opportunity to determine whether RNA foci formation is responsible
for repeat expansion disease pathogenesis. In this proposal, I will optimize my previously developed
inducible RNA aggregation system to improve its usability as a tool to study RNA foci in repeat
expansion disease. Then, I will use this system to determine whether RNA foci formation is
responsible for increased levels of RBP sequestration and cellular toxicity in the repeat expansion
disease C9orf72-type amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD). My
findings will determine whether disruption of RNA foci will directly provide therapeutic benefit for C9orf72-type
ALS/FTD and potentially other repeat expansion diseases. In addition, publication of the first ever tool for
chemogenetic control of RNA aggregation will pioneer an entirely new approach for studying RNA aggregation
events in molecular biology and disease.

Public health relevance
PROJECT NARRATIVE RNA-gain-function toxicity, which is characterized by toxic levels of RNA-binding protein sequestration and the formation of RNA foci, is responsible for the disease pathogenesis of several repeat expansion diseases. However, current methods used to study RNA-gain-of-function toxicity are unable to determine whether RNA foci formation is required for toxic levels of RNA-binding protein sequestration or is merely a byproduct of repeat expansion RNA expression. In my proposal, I will use a method I have previously developed that allows for chemogenetic control of RNA aggregation in order to determine whether RNA foci formation is responsible for RNA-gain-of-function toxicity in the repeat expansion disease C9orf72-type amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD).